Graded Structures for Damage Resistant All-Ceramic Restorations

[unreadable] DESCRIPTION (provided by applicant): Ceramics are widely used in dental and orthopedic prostheses because of their aesthetics, inertness, and biocompatibility. However, ceramics are vulnerable to fracture which accounts for millions of dollars annually in replacement costs and can cause significant patient discomfort and loss of productive lifestyle. Our preliminary investigations have established relations between failure modes and crown thickness, surface conditions, properties of the ceramic, and loading conditions. These findings indicate that monolithic glass- ceramic crowns and veneered alumina crowns are vulnerable to both near-contact occlusal damages and cementation internal surfaces radial fractures, while the veneered Y-TZP crowns are prone to veneer fracture owing to the superior strength of zirconia frameworks. These findings are consistent with clinical reports. It is the fracture problem of ceramic prostheses that motivated us to develop a new generation of damage resistant ceramic prostheses utilizing functionally graded materials. Recent theoretical and experimental advances demonstrate unprecedented resistance to contact damage in functionally graded materials that otherwise cannot be realized in conventional homogeneous materials. Our long-term goal is to develop an aesthetic, strong, thin zirconia based functionally graded material for less invasive all-ceramic posterior crowns and bridges, foreshadowing possibilities for orthopedic and other engineering applications. The objective of this proposal is to fabricate and validate the contact and flexural damage resistances of ceramic layer structures with continuous gradation from both top and bottom surfaces. We propose to achieve this objective through two specific aims: 1. Develop and characterize a new glass/zirconia/glass composite with continuous elastic modulus gradation from outer surfaces (low modulus glass-ceramic) to interior (strong, dense, fine-grain zirconia); and 2. Optimize the function-property (aesthetics, damage resistance-microstructure) relation of glass/zirconia/glass subjected to cyclic loading in water. Our preliminary studies have demonstrated that a functionally graded glass/zirconia/glass sandwich structure with improved damage resistance and aesthetics compared to their bulk zirconia counterparts can be produced by infiltrating a low elastic modulus glass-ceramic into the surfaces of a presintered zirconia. Relevance to public health: Knowledge generated from this investigation will guide design of a new generation of functionally graded ceramic dental and orthopedic prostheses with improved lifetime by resistance to contact damage and flexural fatigue, reducing morbidity and costs of replacement to the public. [unreadable] [unreadable] [unreadable]